Treatment with hrVCP of ApoE4 genetic predisposition to AD by controlling complement mediated neuroinflammation

Project Summary/Abstract
Vaccinia virus complement control protein (VCP) has been shown to have structural and functional similarity
to human complement control proteins. VCP modulates the human and rodent complement system. During
the past two decades, we have studied VCP extensively in a number of preclinical inflammatory disease
models including Alzheimer’s disease (AD) and spinal cord injury (SCI) and demonstrated that controlling
complement mediated inflammation by VCP has significantly improved outcomes, leading to our hypothesis
that VCP can be potentially used for therapeutic treatments of these diseases. AD is one of the most
devastating diseases amongst the aging population in the world and the 6th leading cause of death in the
US. It is well known that amyloid proteins and plaques are associated with activation of several
proinflammatory mediators, especially complement components. Interestingly, ApoE genotypes that
significantly facilitate A- deposit, are strongly involved in regulation of classical complement cascade.
These pro-inflammatory mediators can cause damage on their own as well as working in synergy with each
other, ultimately leading to neurodegeneration. Over time, the damaging role of complement components
overpowers their beneficial effects as the disease progresses. As a result, complement pathways have
become potential targets for developing treatments of diseases such as AD. To provide a proof of concept,
we investigated the role of complement pathways regulated by VCP in AD mice model. In this model, VCP
was shown to be effective in preventing memory loss. To further develop VCP as a potential treatment for
AD, in this SBIR phase I study, we will aim at characterizing high qualify humanized recombinant VCP
(hrVCP) and at the assessment of candidate hrVCP in animal models in a more clinical relevant manner by
an independent CRO company with two specific aims: 1) To subject hrVCP to a full battery of in-house
analytical characterization and stability profiling; ; Specific Aim 2: To validate our previous findings by
testing efficacy of hrVCP in APP/PS1 AD models with collaboration of an independent CRO laboratory. Our
milestone goals include development of active and stable hrVCP pre-formulation in Saline, production of
more hrVCP if resources allow, and validation of efficacy data in AD models from a laboratory other than
our own. If we are successful, PK/safety assessments and other preclinical studies of purified hrVCP
protein will be the goal of Phase II studies, along with even more rigorous safety studies including in vitro
cardiotoxicity, hepatotoxicity and bone marrow toxicity studies in stem cells derived tissue cells. We expect
that the SBIR phase1 studies will lead to development of hrVCP for a commercial scale therapeutic
approach to target the progression of neuroinflammation and neurodegeneration anticipated in AD patients.

Public health relevance
Narrative: In our preliminary studies, we have shown promising results to treat Alzheimer’s disease (AD) in animal models by inhibiting complement pathways with humanized recombinant Vaccinia Virus Complement Control Protein (hrVCP). This project will carry out characterizing a large scale of high quality hrVCP in pre-formulation saline solution that will be then tested in AD animal models for validation of our earlier results by an independent CRO laboratory so that we will be able to seek additional funds from governments and private investors pre-clinical and then clinical studies in animals and humans. If successful, it will contribute to an intervention for AD.